BU Clinical HIV/AIDS Research Training Program (BU-CHART

PROJECT SUMMARY/ABSTRACT
The Boston University Clinical HIV/AIDS Research Training (BU-CHART) program prepares outstanding M.D
and Ph.D. trainees for careers as scientific leaders in HIV/AIDS research, with a focus on research in
disadvantaged and underserved populations. BU-CHART focuses its training plan on four high-priority HIV
research fields that address the substantial challenges that remain to ending the HIV epidemic: 1) substance
use and HIV - a syndemic of substance use disorders and HIV infection fuels HIV outbreaks in the U.S.,
Eastern Europe, and Asia. 2) Tuberculosis and HCV co-infection - comorbidities, including Tuberculosis and
Hepatitis C Virus are leading causes of death among HIV-infected people; 3) HIV transmission and
establishment of latency - HIV incidence remains stubbornly elevated, and early establishment of HIV latency
remains a frustrating puzzle that limits progress to finding HIV cure; 4) HIV treatment and the accelerated
aging process - we still seek safe and effective interventions to reduce the inappropriate immune activation that
accompanies HIV infection and leads to end-organ disease. The training facilities include state-of-the-art
research space at Boston University Schools of Medicine and Public Health and Boston Medical Center, the
largest Safety-net hospital in New England. BU-CHART synergizes with existing training programs on campus,
including the BU Clinical and Translational Science Institute (CTSI), the Providence-Boston Center for AIDS
Research, and other T32- and R25-funded training programs on the BUMC campus. We pair our outstanding
trainees with BU-CHART faculty mentors who are established investigators with NIH-funded research projects
and experience mentoring. We provide a thoughtfully constructed training plan in scientific reasoning and
experimental design, professional development, and the ethical conduct of human research. The result is a
track record of training success. In the past 15 years, BU-CHART trained 26 MD and PhD post-doctoral
fellows, of whom 20 (77%) remain in in academic positions focused on HIV research. Among the 7 trainees
who completed the program in the current grant cycle, 6 now have academic research positions, 3 have
already obtained career development awards, and 2 have career development awards currently under review.

Public health relevance
PROJECT NARRATIVE The Boston University Clinical HIV/AIDS Research Training (BU-CHART) program prepares outstanding M.D and Ph.D. trainees for careers as scientific leaders in HIV/AIDS research, with a focus on research in disadvantaged and underserved populations.